Strengthening global food safety through improved capacities for food control at regional and country levels

Project Summary/Abstract
In today’s globalized world, food safety capacities need to be strengthened everywhere to
enable more rational and effective controls in all countries. The main objective of this project is
to contribute to the strengthening of national food control systems through provision of
authoritative and practical guidance, training materials and capacity development activities in a
number of selected countries.
The proposed approach is based on two complementary pillars, each comprised of activities at
global, and regional/country levels. Pillar 1 deals with the strengthening of risk-based food
controls through increased application of the risk analysis framework with an emphasis on risk
assessment as the basis for food safety regulation and on risk-based programming of regulatory
activities, in particular, risk-based inspections. Risk-based approaches to food control help
minimizing exposure to food hazards, while making more efficient use of the available
resources, that may be scarce for many developing or transition countries. To move from
reactive towards preventive food control systems, food safety professionals must be enabled to
find, generate and utilize relevant data. Newly developed tools, based on proven approaches
used in a range of contexts, will be used to guide assessment, option evaluation and strategic
improvement of risk-based controls. Under the second Pillar, selected food control systems will
be assessed using the recently developed FAO/WHO assessment Tool. Stakeholder
participatory advocacy workshops will be conducted to achieve high-level commitment to
improving food control while priority capacity building activities will be undertaken according to
established targets. By providing support to implement the assessment of national food control
systems, this project will identify food safety capacity needs to be strengthened to enable more
rational and effective controls in all countries. A pool of assessors will also be created by
training food safety specialists in facilitating the food control system assessment process
through sound methodologies. All regional/country activities will be carefully designed to confirm
preliminary assessments, and secure relevant partnerships with national counterparts and
effective planning/implementation of specific activities.

Public health relevance
Project narrative The main objective of this project is to implement a complementary set of capacity building actions in a number of selected countries focused on risk-based practices and overall comprehensive assessments of food control systems to improve national food control frameworks. Risk-based approaches to food control and identification of the weaknesses in the food control system help minimizing exposure to food hazards, while making more efficient use of the available resources, that may be scarce for many developing or transition countries. In the development and delivery of this project, high importance is placed on coherence with other activities, both in FAO and beyond, to support an optimal and a sustainable outcome, while linkages will be ensured between the technical and the political frameworks to facilitate policy changes based on the improved understanding about where the risks lie.